Role of EGFR Ligands in Neoplasia

[unreadable] DESCRIPTION (provided by applicant): Important, clinically relevant insights have emerged from our basic studies of the trafficking and processing of EGF receptor (EGFR) ligands in the context of polarized epithelial cells. TGFα and amphiregulin (AR) are delivered preferentially to the basolateral surface where they are cleaved by TACE/ADAM-17. Mature soluble TGFα then is avidly taken up by basolaterally restricted EGFRs. We have identified and characterized two TGFα cytoplasmic tail-interacting proteins (Naked2 and MAGI-3) that regulate, respectively, the fidelity and efficiency of TGFα delivery to the basolateral surface. Naked2 associates with TGFα-containing exocytic vesicles as they emerge from the Golgi, and escorts these vesicles to the basolateral plasma membrane where they dock and fuse in a Naked2 myristoylation-dependent manner. Functional Naked2 appears to be required for the proper basolateral delivery of TGFα since TGFα is "trapped" in the cytoplasm of myristoylation-deficient Naked2-expressing cells. Full length Naked2 protein is downregulated in colorectal cancer where TGFα immunostaining is often cytoplasmic. Studies are proposed to further examine the function of Naked2 and MAGI-3, and to test the hypothesis that trafficking of TGFα in polarized epithelial cells correlates with the oncogenic potential of an epithelial cell in that proper basolateral trafficking of TGFα contributes to the maintenance of epithelial homeostasis whereas aberrant trafficking of TGFα is tumor-promoting. [unreadable] [unreadable] In contrast to TGFα, AR is delivered to the basolateral surface in a Naked2-independent manner. AR binds basolateral EGFRs but less avidly than TGFα. Exogenous AR, but not TGFα, disrupts epithelial junctional integrity leading to an epithelial to mesenchymal-like transition. We hypothesize that a consequence of impaired delivery of TGFα to the basolateral surface is that AR binds "unoccupied" basolateral EGFRs, perturbs epithelial polarity and predisposes the cell to tumor progression. Based on our success in identifying proteins that functionally interact with the cytoplasmic tail of TGFα, we propose to conduct a similar analysis with the cytoplasmic tail of AR. [unreadable] [unreadable] Overall, these studies will elucidate mechanisms underlying the delivery of TGFα and AR to the basolateral surface of polarized epithelial cells, enhance our understanding of the role of these two EGFR ligands in epithelial cell biology and lead to important insights into the pathogenesis of colorectal cancer and provide novel, more effective ways to diagnose and treat this disease. [unreadable] [unreadable] [unreadable]